REFERENCE RANGE FOR THE QUS 2 ULTRASONOMETER FOR EVALUATION OF OSTEOPOROSIS

The purpose of this study is to determine normative ultrasound measurements for women age 35-84 using the QUS-2 ultrasonometer (MetraBiosystems; Mountainview, CA).